Drug Screening Platform in the Light-Responsive Human Eye

Blinding diseases rob independence from millions of people in aging societies with poor metabolic and
cardiovascular health. There are currently almost 1,000 planned or active clinical trials for investigational new
drugs (INDs) to address AMD, diabetic retinopathy, glaucoma or inherited retinal degenerations. In addition,
stem cell and gene therapies or even whole eye transplantation to restore vision is an active area of research,
currently mostly advanced using animal models. Overall, biomedical research, including pharmaceutical
companies and contract research organizations, use about 100 million mice and 100,000 monkeys every year.
Despite this, translation success has remained poor, at ~5-10%. Our long-term goal is to improve the translation
probability of INDs that enter clinical trials using functionally viable human donor tissues to improve patient care
and reduce animal experiments and suffering. This goal is achieved by developing new technology and assays
to test efficacy and safety of INDs preclinically in functionally viable postmortem human donor eyes. Our recent
ground-breaking work has demonstrated revival of in vivo-like light signaling in postmortem human retinas. Our
central hypothesis is that these human retina samples can be maintained functional for >48-hrs and used
efficiently to screen the efficacy of INDs to protect human neurons and glia from stressors caused by retinal and
neurodegenerative disease before clinical trials. The rationale for this project is that demonstrating that an IND
is not expected to work in human tissue pharmaceutical companies can save >$10M/IND and significant number
of animals by preventing those INDs not expected to work in human tissues from advancing to in vivo animal
testing or clinical trials. On the other hand, our platform can promote advancement of an IND to the clinical trial
and ultimate approval where it could have been otherwise deemed ineffective based on animal experiments,
thus, potentially delivering new life- or sight-saving treatments and multi-billion-dollar revenues for
pharmaceutical companies. Eyescreen, Inc. will test the central hypothesis in Phase 1 and 2 of this SBIR project.
Phase 1 proposes two specific aims. Aim 1: Establish novel ex vivo preclinical models for human ocular
diseases; Aim 2: Development of a multichannel drug screening platform in the light-responsive mouse and
human retina. These aims will scale up access to viable human eyes by restoring and preserving in vivo-like light
responsiveness in eyes procured up to 1-h and stored >48-h post-mortem as well as establish novel new high-
throughput platform (Aim 2) for testing impact of INDs on physiology of human retinal neurons and glia exposed
to disease stressors like ischemia and inflammation (Aim 1). In Phase 2 Eyescreen Inc., in collaboration with the
Vinberg lab, will use these assays to screen clinically approved/failed drugs and compound libraries to test the
hypothesis that our platform can improve translation probability. In addition, Phase 2 will expand the utility of our
platform to study the impact of not only small-molecule drugs, but also gene therapies, in aged and diseased
human eyes.

Public health relevance
The research proposed by Eyescreen, Inc. addresses the critical need for more accurate preclinical drug testing models by developing "InSight," a platform that evaluates the efficacy of ophthalmic drugs in ex vivo human retinal tissue subjected to disease stressors. By testing drugs directly on human tissue that accurately mimics in vivo conditions, InSight aims to improve the translation of preclinical findings to clinical trials, enhancing drug development efficiency for blinding retinal diseases like AMD, DR, and glaucoma. This approach promises to shorten drug development timelines, improve patient outcomes, and reduce both the cost and the number of animals used in drug testing.